Women's health: interplay of maternal diet and key demographics on neurological health in the rural frontier and remote West

Project Summary/Abstract
This INBRE administrative supplement expands the capacity of Idaho to conduct women’s health research.
The proposed research is within the scope of the parent INBRE award (P20 GM103408). The project fits within
the broad and inclusive Idaho INBRE scientific theme of ‘cell signaling,’ develops investigator research
capacity, and provides research opportunities to students. Compromised mental, cognitive, and emotional
health is common in US women during the perinatal period, and those living in the rural frontier and remote
West are disproportionately affected. Factors underlying the high prevalence of these health disorders in
women are complex, but poor diet is a suspected, prominent contributing factor. We propose a longitudinal,
repeated-measured, observational study of perinatal women living in Idaho, Montana, and Wyoming. We will
test the hypotheses that 1) perinatal dietary patterns of women in the rural frontier and remote West vary by
key demographic variables (e.g., household income) and 2) women consuming certain dietary patterns have
better mental, cognitive, and emotional wellbeing assessments compared to those consuming other types of
diets. These hypotheses will be tested in two specific aims. The first aim will use validated tools to characterize
acute and chronic perinatal dietary patterns of the study subjects and determine if variation in these patterns is
related to household income and other key demographics. The second aim will use rigorous methodologies to
document associations between dietary patterns and perinatal maternal mental health, cognitive function, and
emotional wellbeing. Identification of dietary patterns associated with better maternal neurological health is the
first step in designing interventions to facilitate positive behavior changes and improve prenatal care. As such,
this study will provide foundational data to inform the design of and sample size calculations for future studies.
This study will also increase the number of students with training in women’s health-related biomedical
sciences and provide preliminary data for an R01 proposal. The long-term goal of our research program is to
implement nutrition education interventions to facilitate positive dietary and behavior changes and ultimately
improve nutritional and neurological health of women living in the rural frontier and remote West.

Public health relevance
Project Narrative Relevance The proposed research project is relevant to public health because compromised mental health, cognitive function, and emotional wellbeing is common in US women during the perinatal period. Women in the rural frontier and remote West are disproportionately affected. In this study, fundamental knowledge about the interplay between dietary patterns and key demographic variables on maternal neurological health will be determined as a first step in developing interventions for this underserved group.